Kinases: Next-Generation Insights and Approaches

ABSTRACT Support is requested for a Keystone Symposia meeting entitled Kinases: Next-Generation Insights and Approaches, organized by Drs. Reid M. Huber, John Kuriyan and Ruth H. Palmer. The meeting will be held in Breckenridge, Colorado from March 5-9, 2017. Decades of advances in both basic and applied research have unequivocally established the importance the kinase family of phosphotransferase enzymes in virtually every aspect of organismal homeostasis. These advances have yielded transformative therapeutic approaches to disease, most notably in the field of cancer where kinase inhibition is helping to fulfill the promise of precision medicine. Yet even today, our perspectives on the complexity of this class of enzymes continues to evolve, and many of the most exciting advancements in the field are being made by applying modern-day insights and technological approaches to the diverse roles the enzymes can play in health and human disease. This meeting will be devoted to exploring this innovative leading edge of basic and applied kinase research, and will bring together leading researchers from academic, clinical and pharmaceutical settings to explore and define the new horizons in the field of kinase biology, with a focus on cancer research and translational development.

Public health relevance
PROJECT NARRATIVE Kinases represent one of the most fundamental regulatory proteins found in living organisms, and play diverse roles in health and human diseases. Studies of kinases have expanded our understanding of kinase function and cellular regulation, and advanced in a fundamental way our ability to translate basic biochemistry and cell biology into therapies for disease; not only, but most notably, in the field of cancer. The Keystone Symposia conference on Kinases: Next-Generation Insights and Approaches will assemble researches studying kinase biology through the advanced technologies of today – namely phopshoproteomics, systems biology, developmental biology, genetics, chemistry, and cell physiology – with the goal of disrupting conventional thinking in the space by illustrating novel biochemistry and pathway dynamics to disrupt dogmatic paradigms, challenging conventional thinking and infusing basic science into our emerging approaches to treat human disease.